Regulation of Age-Associated Heterochromatin Formation

This application for a Mentored Research Scientist Development Award is to facilitate Dr. Jill Kreiling's transition to an independent investigator in the field of aging biology. Her long-term goals include establishing an independent research program focused on advancing our understanding of heterochromatic changes that occur during the natural aging process. To achieve these goals she will follow a structured career development and training plan that includes training practical laboratory techniques and in bioinformatic analyses; university and extramural courses; attending seminars, meetings and conferences; and training in grant writing and laboratory management skills. This plan will be implemented under the supervision of the primary mentor, Dr. John Sedivy, who is an expert in the field of aging biology and has considerable experience with the analysis of genome-wide studies. Dr. Peter Adams, a leader in the field of chromatin biology, will serve as a co-mentor, along with Dr. Robert Reenan who specializes in RNA biology. In addition, Dr. Charles Lawrence will provide guidance with the bioinformatic approach to genome-wide analyses. There is a growing body of evidence that chromatin undergoes reorganization during normal aging. This is accompanied by a corresponding change in gene expression. It is reasonable to expect that these two processes may be connected. However, the epigenetic mechanisms of this extensive rearrangement of the chromatin are virtually unknown. In this application we propose to study the mechanisms that regulate age- associated heterochromatin formation in post-mitotic tissues. Our preliminary data suggest an increase in facultative heterochromatin incorporating the highly repressive histone variant macroH2A in mouse and baboon skeletal muscle. Recent evidence points towards a role of small non-coding RNAs (ncRNAs) in the deposition of repressive heterochromatin marks. The synthesis of many miRNAs (a subclass of ncRNAs) is regulated by Polycomb group (PcG) repression, and our preliminary data suggest a decrease in PcG repression in old animals. We will study the role of ncRNAs in the regulation of age-associated heterochromatin formation in skeletal and cardiac muscle from mice and rhesus monkeys. Specifically we will correlate specific ncRNAs to sites of age associated heterochromatin formation and we will investigate the regulatory elements present in the ncRNA genes. Our hypothesis is: An age-associated reduction in PcG repression leads to activation of certain miRNA genes, whose products trigger age-associated heterochromatin formation at specific sites on the genome. Specific Aim 1: We will begin these studies by identifying the specific chromatin states that correlate with age in post-mitotic tissues. In addition, we will determine if certain dietary interventions (calorie restriction and resveratrol) can delay the onset of this age- associated phenotype. Specific Aim 2: This information will be used to design ChIP-seq assays to determine the regions of the genome susceptible to age-associated heterochromatin formation. The ncRNA populations will be characterized by RNA-seq of the transcriptome to identify ncRNAs subject to age associated increases in expression. The sequences of the ncRNAs showing an age-dependent up-regulation will be correlated with sequences of the genome showing age-associated heterochromatin to determine potential sites of RNA- dependent deposition of silencing marks. Specific Aim 3: Markers of PcG repression will be investigated to determine if there is a decrease in PcG repression with age. The promoter regions of the associated miRNA genes will be analyzed to determine if PcG repressive elements are present that could regulate expression. Finally, we will verify our results with mechanistic studies in cultured human fibroblasts to show that the expression of specific ncRNAs are repressed by PcG regulation in young cells and this repression is lifted in older cells leading to expression of the ncRNA and age-associated heterochromatin formation. Taken together this project will broaden our understanding of the mechanisms and processes involved in the regulation of age- associated heterochromatin formation.

Public health relevance
Project Narrative. As organisms age there are changes in gene expression that contribute directly to aging phenotypes. These changes in gene expression are thought to result from alterations in the structure of the chromatin to form repressive heterochromatin. We will study the regulation of chromatin structure modification to provide insight into the mechanisms of age-associated changes in gene expression and to possibly identify interventions that delay these processes. __SpecificAimsTextDelimiter__ Specific Aims There is a growing body of evidence that chromatin undergoes reorganization during normal aging. This is accompanied by a corresponding change in gene expression. It is reasonable to expect that these two processes may be connected. However, the epigenetic mechanisms of this extensive rearrangement of the chromatin are virtually unknown. Our data suggest an age-associated increase in facultative heterochromatin incorporating the highly repressive histone variant macroH2A (mH2A) in mouse skeletal muscle [1]. This finding is interesting since skeletal muscle is a fully differentiated tissue and muscle cells do not replicate. Changes in heterochromatin have been shown to be associated with replicative cellular senescence, a physiological state in which the cell stops dividing and undergoes extensive changes in gene expression. Our data suggests that chromatin changes also occur in post-mitotic cells. Our goal is to understand the regulation of age-associated changes in heterochromatin in post-mitotic tissues. Recent publications establish small, non-coding RNAs (ncRNAs) as important components of a transcriptional gene silencing complex that triggers the formation of repressive heterochromatin, and this mechanism appears to be conserved across a broad range of organisms from yeast to mammals. These findings raise the intriguing possibility that ncRNAs are involved in the establishment of age-associated heterochromatin. The promoter regions of many miRNA genes (a subclass of ncRNAs) are regulated by Polycomb response elements (PREs), which bind Polycomb group repressive complexes (PRCs) leading to gene silencing. Several components of the PRC complexes are known to decrease with age, and our preliminary data suggest PRC repression decreases with age. An age-associated decrease in Polycomb group repression may lead to a de-repression of miRNA genes that are normally silenced in younger animals. Synthesis of these de-repressed miRNAs could trigger heterochromatinization and may be responsible, in part, for the age-associated increase in facultative heterochromatin. These findings lead us to our working hypothesis: An age-associated reduction in PcG repression leads to activation of certain miRNA genes, whose products trigger age-associated heterochromatin formation at specific sites on the genome. We will test this hypothesis by addressing the following Specific Aims: Specific Aim 1: Characterize the distribution of cells expressing specific markers of age-associated heterochromatin in mouse and rhesus monkey post-mitotic tissues. Skeletal muscle and heart from young and old mice and rhesus monkeys will be examined for specific repressive heterochromatin marks (mH2A, H3K9me3, H4K20me3, HP1¿) using a single cell fluorescence microscopy based assay. Tissues from calorically restricted mice and resveratrol treated rhesus monkeys will be included to determine the effects of these dietary interventions on age-associated heterochromatin formation. The role of mH2A1 in the heterochromatinization process will be investigated using tissues from mH2A1 knock-out mice. These experiments will expand our understanding of age-associated heterochromatin. Specific Aim 2: Investigate the relationship between small RNAs and age-associated heterochromatin formation. Our goals in Specific Aim 2 are aimed at understanding how changes in the ncRNA transcriptome are associated with the formation of age-associated heterochromatin. We begin with deep sequence analyses of small ncRNA transcriptomes in normal aging conditions in mouse and rhesus monkey skeletal muscle. To correlate ncRNAs with genomic targets we will identify regions of the genome containing age-associated repressive heterochromatin through Chip-seq analyses. The two datasets will be compared to identify potential sites of ncRNA-induced heterochromatin formation. Taken together, these experiments will give us insight into the interaction between ncRNAs and specific sites of age-associated heterochromatin. Specific Aim 3: Examine the role of Polycomb group proteins in heterochromatic changes associated with age. Specific Aim 3 will investigate the role of Polycomb repression in regulating age-associated heterochromatin formation. We will investigate the extent of Polycomb repression in young and old skeletal muscle and heart tissues from mouse and rhesus monkey by examining histone H3 lysine 27 methylation, histone H2A ubiquitination of lysine 119, and levels of the Polycomb repressive complex 1 component BMI1. Tissues from calorie restricted mice and resveratrol fed rhesus monkeys will be included to determine the effects of these dietary interventions on the age-associated reduction of PcG repression. The promoter regions of the genes encoding the ncRNAs identified in Specific Aim 2 will be examined for Polycomb repressive elements to determine if they are controlled by PcG repression. Mechanistic studies using cultured human embryonic lung fibroblasts will be performed to confirm the roles of each of the components found to be significant (Polycomb group proteins, ncRNAs, and repressive heterochromatin marks) in regulating age- associated heterochromatin formation.